Hosting, Help Desk, and Support of NIAID/DAIDS Learning Management System

OPM provides educational and training services to approximately 40 agencies to satisfy their annual OMB mandated training requirements through the use of this shared environment to maximize the cost savings to the Government. In support of this mission, NIAD/DAIDS requires Hosting, Help Desk and Technical Support services for the NIAID/DAIDS Learning Management System (LMS).